Role of Activin Type II Receptor Signaling in Muscle Hypertrophy, Obesity, and Weight Loss

Project Summary
GLP-1 receptor agonists and GLP-1/GIP dual agonists profoundly decrease body weight in association with
significant cardiometabolic benefits. These therapeutic agents are being widely adopted for obesity treatment in
the U.S. Certainly, lowering fat mass is metabolically advantageous; however, reduction of lean mass, especially
skeletal muscle mass, is associated with poor health outcomes including reduced energy expenditure that could
contribute to weight regain and functional defects in certain patient populations. Lean mass loss during GLP-1
receptor agonism is as great or greater than dieting or bariatric surgery. Discontinuing therapy leads to rapid
weight regain, favoring increased adiposity and limited muscle growth. Thus, a major goal of next generation
anti-obesity agents should be to maximize quality weight loss by reducing fat mass while preserving (even
increasing) lean muscle mass. Myostatin and other TGF-b-like ligands, such as activins, are potent negative
regulators of skeletal muscle mass acting primarily via the activin type II receptors (ActRII). Blockade of ActRII
in both rodents and humans drives increased muscle mass that is associated with reductions in adipose tissue.
The holy grail for an obesity treatment is an approach that maximizes reductions in fat mass while sparing lean
tissues such as skeletal muscle. Excitingly, recent published and preliminary data in this application show that
bimagrumab co-treatment in animals receiving semaglutide (a GLP-1 agonist) leads to even greater reductions
fat mass while preserving functional lean mass in mice. These findings indicate that ActRII blockade protects
against muscle loss and drive increased fat loss during calorie deficit, potentially leading to more durable and
sustained metabolic benefits and diminishing susceptibility to “rebound” weight gain. In Aim 1 of this proposal,
the effects of ActRII on systemic energy balance and metabolism both during and following the cessation of
GLP-1/GIP receptor agonism will be explored. In Aim 2, the tissue specific mechanisms of ActRII blockade in
the control of muscle and adipose tissue physiology will be elucidated. Collectively the experiments in this
proposal will address critical knowledge gaps regarding how ActRII blockade alters muscle, adipose tissue and
whole-body energy metabolism when given as a mono-therapy or in combination with GLP-1/GIP receptor
agonists laying the foundation for future therapeutic opportunities targeting body composition for enhanced
weight loss quality in obesity.

Public health relevance
Project Narrative The goal of this proposal is to define the molecular mechanisms downstream of activin type II receptor signaling that are relevant to metabolic health. We will explore the potential benefits of genetic or pharmacological blockage of this pathway, alone or in combination with anorexic agents, including GLP-1/GIP agonists recently approved for treatment of obesity, as a step toward an ideal therapeutic approach for quality weight loss in obesity.